Midcareer Investigator Award in Patient-Oriented Research in Pediatric Asthma

The candidate is currently an Associate Professor of Pediatrics at Vanderbilt University and a clinical
investigator and epidemiologist whose research investigations are thematically linked through their focus on
delineating prenatal and early life determinants of asthma and lung function to inform efforts to increase
protective exposures, decrease adverse exposures, and inform prevention efforts. Prenatal exposures, such
as diabetes during pregnancy, have the potential to have lifelong effects on respiratory health through
associated systemic inflammatory, immunologic, or oxidative stress changes that influence the developing
pulmonary or immune system of the fetus. The candidate’s current patient-oriented research investigations
include prenatal exposures such as maternal traumatic stress, antioxidant and anti-inflammatory nutritional
exposures, and oxidative stress, and she proposes to expand to investigations of diabetes during pregnancy
and child asthma and lung function in prospective and novel cohorts of mother-child dyads. The candidate has
developed a plan to increase and strengthen her skills in both patient-oriented research and mentoring to
include formal research mentor training. The candidate proposes a mentoring plan for trainees to facilitate their
effective transition from junior clinical investigator to independent investigators.

Public health relevance
Asthma is common in childhood and a growing body of evidence suggests that metabolic derangements during pregnancy play a role in asthma inception. Diabetes during pregnancy has the potential to have lifelong effects on child respiratory and immune health through associated systemic inflammatory, immunologic, or oxidative stress changes that influence the developing pulmonary or immune system of the fetus. The aims of this study will be met by allowing the candidate to mentor new clinical investigators in patient-oriented research and conduct studies of prenatal risk factors for asthma, including prenatal diabetes, in a research program that serves to delineate risks factors and mechanisms of disease for asthma prevention.